Evaluation of a PPMO Inhibitor of Lassa Virus Infection and Disease in a Guinea Pig Model

Evaluation of a PPMO Inhibitor of Lassa Virus Infection and Disease in a Guinea Pig Model
ABSTRACT:
Lassa fever (LF) is caused by infection with Lassa virus (LASV), and is currently a major human disease problem
in much of West Africa, causing thousands of deaths annually. Recent outbreaks of LF have been characterized
by an increased number of cases and larger geographic footprint compared to previous outbreaks, and constitute
a burgeoning public health crisis. In addition, the number of LF cases imported into non-endemic countries is
growing, and there is also concern that LASV could be used as an agent of biological warfare. There is as yet
no licensed vaccine or specific antiviral therapeutic to intervene against LASV-infections and treat patients with
LF, and current treatment options have poor efficacy. There is therefore an immediate and critical medical need
for new antiviral compounds to address LASV. Peptide-conjugated phosphorodiamidate morpholino oligomers
(PPMO) are a class of single-stranded-nucleic acid analogs that can enter cells readily and interfere with the
production of viral proteins through steric blocking of complementary RNA. PPMO have shown considerable
antiviral efficacy in vitro and in vivo against a number of RNA viruses, including several arenaviruses. We
propose to synthesize two PPMO targeting highly conserved RNA sequences in the genomic termini of the LASV
genome. Each PPMO will be tested in a non-cytotoxic dose-range for antiviral activity against several genetically-
disparate strains of LASV. The PPMO exhibiting the highest antiviral efficacy in vitro will then be advanced to
testing in a guinea pig model of LASV disease. Animal weight, temperature, appearance and behavior, along
with mortality and viral titer in several tissues will be monitored. This study is designed to evaluate the ability of
PPMO to reduce morbidity and mortality in a small-animal model of of severe LASV-disease. If successful, the
project will produce an inhibitor that would be immediately useful as a research reagent against any strain of
LASV and as a candidate for further development as a therapeutic agent against LASV infections in humans.

Public health relevance
Project Narrative. Lassa fever is a major public health problem in West Africa, causing around 5,000 deaths annually. Lassa fever is caused by Lassa virus and there is currently no vaccine or effective antiviral therapy available to address Lassa virus infection and disease. This project seeks to determine if peptide-conjugated phosphorodiamidate morpholino oligomers (PPMO) can effectively reduce morbidity and mortality in an experimental guinea pig model of severe Lassa virus disease.